Conference Funding: Society of General Physiologists "Molecular Evolution in the Membrane"

Project Summary
This proposal requests funds to support the 77th Annual Symposium of the Society of General Physiologists
(SGP) entitled `Molecular Evolution in the Membrane' from September 4th to September 8th, 2024, at the
Marine Biological Laboratory (MBL) in Woods Hole, MA. SGP symposia are international meetings for
physiologists, biophysicists, and neuroscientists of all career stages. A different meeting theme is selected
each year, in order to draw focus to an emerging or particularly timely area of research within the field of
physiology. The 2024 meeting will highlight cutting edge research in membrane proteins drawing on the tools
of molecular evolution. Molecular evolution is a powerful tool to understand the origins of functional diversity in
proteins, and has catalyzed a range of discoveries pertaining to diverse topics like drug discovery, structure
prediction, and the mechanistic underpinnings of complex physiologies. The 2024 meeting will bring together
~150 scientists and trainees to discuss cutting-edge fundamental research that applies the tools of molecular
evolution to understanding the mechanisms of transporters, ion channels, and receptors with significance to
physiology and human health. This meeting size is large enough to represent a diverse range of research
areas, and small enough to maximize individual discussions and foster collaborative interactions between
students, postdoctoral fellows, early-career investigators, and established leaders in their fields. The
organizers, Drs. Randy Stockbridge (University of Michigan) and Lucy Forrest (NIH/NINDS) have significant
expertise in experimental and computational approaches to understand mechanisms of membrane transport
proteins. A highly accomplished and diverse international group of 24 speakers that will contribute to a
synergistic environment at the meeting. The meeting program also includes roundtable discussions on topics
of diversity/inclusivity and professional development, along with poster sessions, short talks selected from
abstracts, and 2-minute poster preview talks. The SGP has a long track record of providing outstanding
administrative support, and the Marine Biological Laboratory venue is historical, conveniently located, and an
excellent meeting environment. All these factors will help ensure a successful meeting.

Public health relevance
Narrative This proposal requests funds to support the 77th Annual Symposium of the Society of General Physiologists (SGP) titled `Molecular Evolution in the Membrane' from September 4th to September 8th, 2024, at the Marine Biological Laboratory (MBL) in Woods Hole, MA. The SGP annual symposium has an established international reputation as a leading meeting for physiologists, biophysicists, and molecular biologists at all career stages. The overarching goals of the 77th edition are to highlight cutting edge methods and transformative technologies that have led to advancements in understanding the origins of functional diversity in ion channels, transporters, and receptors, inspire and recognize young and diverse investigators who carry out this research, and to foster interdisciplinary collaborations across fields such as biophysics, physiology, structural biology, bioinformatics, and phylogenetics, which will contribute to foundational science in support of breakthroughs in human health.